CARDIA CHICAGO FC DIVERSITY SUPPLEMENT - TASK AREA E

This project proposes to investigate whether individual-level, interpersonal-level, and neighborhood-level assets confer favorable Cardiovascular health (CVH) in a sociodemographically diverse population in CARDIA. It will create a composite score by linking external business data to the existing CARDIA data for the years in which participant’s addresses have been geocoded, and calculating a spatial-clustering measure to quantify the extent to which the number of assets are available in the participant’s neighborhood. This project seeks to advance the literature on multi-level psychosocial assets and ideal CVH. The CARDIA Study is the ideal platform for this in-depth analysis due to its broad range of available psychosocial assets, unique geospatial coding of residents at many exams, and longitudinal assessment of CVH.